Modernization of the Ohio State University Bevis Hall Zebrafish Facility

SUMMARY
The goal of this proposal is to enable a comprehensive modernization of an aging system in the shared
zebrafish research facility in Bevis Hall at the Ohio State University. The modernization proposal will align the
capabilities of the zebrafish facility with modern demands on zebrafish science and increase capabilities to
allow affiliated researchers to consider experiments that were previously unattainable. The zebrafish facility in
Bevis Hall houses the fish of three core- and five additional users. The research supported by this facility spans
neural development, heart regeneration, systems neuroscience, cancer research and nutrition.
The renovation will allow automatic monitoring and control of critical water parameters and automatic feeding.
These advances will increase research reproducibility, reduce waste, and dramatically shorten generation time.
The expected reduction in size and growth variability of adult and juvenile zebrafish will allow for new research
avenues in these stages. The decrease in time from hatching to sexual maturity of zebrafish will increase the
amount of generated transgenic and mutant fish available to researchers at The Ohio State University and
beyond. The proposed modernization will also centralize water filtration and eliminate food-waste, reducing the
environmental footprint of the facility. Increasing the reproducibility of experiments through better controlled
feeding and water parameters will allow reducing the amount of animals used in experiments.

Public health relevance
The zebrafish is a powerful model system with a large, diverse, vibrant, and growing worldwide community of researchers. We propose an integrated update and modernization plan for the Ohio State zebrafish facility in Bevis Hall to support robust and reproducible research using this model at the Ohio State University. This fish facility is used by researchers studying diverse questions in development, behavior, regeneration and cancer and the upgrade will therefore foster research that is relevant to human biology in health and disease.